BIORAD ChemiDoc MP imaging system

Abstract / Summary
The vast majority of all secreted and plasma membrane proteins are synthesized on membrane-bound
ribosomes at the endoplasmic reticulum (ER). Ribosomes synthesizing this subset of proteins are targeted to
the ER membrane by the signal recognition particle (SRP). SRP binds to signal sequences as they emerge from
the ribosome as part of the growing polypeptide chain. SRP then hands over the nascent polypeptide to the
Sec61 translocon for movement into or across the ER membrane bilayer. Protein folding in the ER lumen
proceeds co-translationally. In the event of protein misfolding, a signaling network, the “unfolded protein
response (UPR)”, is activated that rebalances the ER’s protein folding capacity with the load of proteins entering
the ER. IRE1 is one of the UPR’s main protein misfolding sensors. It is a bifunctional kinase/RNase with a
lumenal domain that is activated by unfolded protein binding. It signals through a non-conventional mRNA
splicing reaction, utilizing its cytoplasmic RNase domain to excise an intron from the mRNA encoding the
transcription factor XBP1. XBP1 drives expression of a host of chaperones, protein folding factors, and
component of the protein transport and degradation machinery to reestablish homeostasis. IRE1 also degrades
select ER-bound mRNAs, thereby reducing the ER protein-folding load in a reaction termed “regulated IRE1
dependent decay (RIDD)”. IRE1 can directly interact with the co-translational translocation machinery, including
the ribosome, SRP, and Sec61 translocon. These data (and supporting evidence) suggest that IRE1, at least in
part, performs its functions in physical contact with ER-bound ribosomes. When activated, however, IRE1 forms
large oligomeric clusters. We recently visualized these clusters in intact cells using correlative light and electron
microscopy. Our high-resolution cryo-tomograms demonstrate that IRE1 clusters are convoluted networks of
narrow, anatomosing ER tubes. Surprisingly, these clusters are entirely devoid of membrane-bound ribosomes.
This poses a paradox, suggesting that active IRE1 must exist in at least two sub-populations, one composed of
small oligomers that can ribosome- and/or SRP-associate, the other composed of large ribosome-free IRE1
clusters. We will map IRE1’s target mRNAs and mechanistic roles to these states. Specifically, we will: (1)
Dissect the mechanistic principles of substrate selection by IRE1. (2) Determine the atomic structure of IRE1
complexed to ribosomes, translocon, and/or SRP using single-particle cryo-EM. (3) Identify the sub-cellular
birthplaces of IRE1-spliced and RIDD-cleaved mRNAs. (4) Assemble IRE1 cluster of defined stoichiometry in
vitro and in cells and assess functional outputs with biochemical and cell-based assays. Defects in proteostasis
lie at the heart of an ever-expanding list of diseases. The proposed experiments aim to define how mammalian
IRE1 selects its mRNA targets and what key molecular players it associates with in its functional states. The
work will not only lead to a deeper understanding of the cell biology of IRE1 but also promises to open new
avenues for clinical application in cancer, neurodegeneration and other diseases.

Public health relevance
Project Narrative Most secreted and membrane-embedded proteins are co-translationally targeted to the endoplasmic reticulum (ER), where ER-resident sensors constantly monitor the status to ensure fidelity in protein folding. We will investigate the timing and location of one of these sensors, IRE1, with respect to protein synthesis, which may determine how effectively the cell can counteract ER-stress resulting from an imbalance in the ER’s capacity. A molecular understanding of how IRE1 functions during co-translational protein targeting is of profound significance to our understanding of cell physiology and pathology at a most fundamental level, including that of many diseases.